Administration, Research Coordination, and Planning

OTHER PROJECT INFORMATION – Project Summary/Abstract
Core A – Administration, Research Coordination, and Planning
The administrative core provides for coordination, collaboration, integration, and planning in all aspects of the
research process. The core monitors the activities and products of the P01 projects, manages finances and
personnel, shares program information both internally and publicly, coordinates shared resources, disseminates
findings, and links researchers to training opportunities, data resources, technical expertise, and dissemination
mechanisms. The core organizes working group meetings, workshops, and conferences that bring people
together to share and discuss Program Project research and findings, and to learn from outside experts. The
core also provides intellectual leadership to the program project, including identifying and drawing out cross-
project overlaps and synergies, and substantive integration, synthesis, and planning.
Both the convening and integrative roles of the core will assure regular interactions between economics
researchers, collaborators and advisors with analytic and caregiving expertise for people living with Alzheimer’s
disease and related dementias (ADRD), and a wider community of health care professionals with experiential
knowledge and perspective on the treatment and care of people with ADRD. A key responsibility of the core is
to create opportunities for the team to learn about and incorporate in their research plans the significant
qualitative differences in decision-making about care for people with ADRD, the elevated role of families and
other caregivers, and how they weigh the various health and functional outcomes of alternative treatment
decisions, particularly for patients with more serious dementia.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The administrative core transforms a set of independent research projects on understanding and improving healthcare decision-making and outcomes for people living with Alzheimer's disease and related dementias (ADRD) into a vibrant programmatic endeavor. It encompasses not just administrative support, but also intellectual leadership, substantive integration, and interactive opportunities for cross-project collaboration and learning from practitioners and community experts in caring for people with ADRD.